Flexor tendon intrinsic healing and intervention strategy development

ABSTRACT
Hand flexor tendon injuries are common and often occur in a young working-age population resulting in considerable
disability and economic impact. Surgical direct repair immediately after tendon injury is the clinical standard in practice.
However, clinical and functional outcomes following tendon repair remain unsatisfactory due to restrictive adhesions and
poor digital motion, often resulting in multiple surgical revisions, such as tenolysis or tendon grafting. It is known that
both intrinsic and extrinsic healing mechanisms are involved in flexor tendon healing. Intrinsic healing is accomplished
by cellular productivities from the cells within the tendon resulting in fewer adhesions and better function. In contrast,
extrinsic healing relies on the healing from outside tissues, leading to adhesion and scar formations that bond to the
tendon with surrounding tissues and diminish hand function. Therefore, research strategies to improve clinical outcomes
have focused on either enhancing intrinsic healing or eliminating extrinsic healing, or a combination of both. It is also
recognized that some intrinsic healing elements (IHE) involve tendon intrinsic healing capacity including flexor
vinculum (FV) for tendon blood supply and epitenon cells (ECs) within the tendon for tendon regeneration. However, it
is still unknown if and how these IHEs would affect the intrinsic healing ability. Since the IHEs can be damaged during
tendon injury, it is critical to better understand the intrinsic healing associated with IHEs, which not only help to bridge
the scientific gap between clinic and research in this field, but also improve the intervention strategy development.
Recently, we have successfully developed a novel turkey animal model, which is similar to the human flexor tendon in
size, anatomy, structure, function, and most importantly the intrinsic healing capacity. This unique animal model provides
an ideal opportunity to investigate the effects of the IHE on tendon intrinsic healing. Furthermore, we have recently
explored a purified exosome product (PEP) developed by Mayo Center for Regenerative Medicine in the ISO-5 Good
Manufacturing Practice (GMP) Facility to improve tendon intrinsic healing with promising results. We have also
developed a lubricating barrier material using carbodiimide derivatized synovial fluid plus gelatin (cd-SF-G) to reduce
adhesions in the tendon graft; but it has not been tested in flexor repair model. Therefore, Aim 1 of this proposal is to
determine the role of two major factors of IHEs including FV and ECs on tendon healing and functional restoration using
our novel turkey flexor tendon injury model. This specific aim, if successful, we will address a critical barrier for the
understanding of flexor tendon intrinsic healing mechanism and advance the current knowledge in hand surgery. Aim 2
will define the effectiveness of our novel interventions using PEP for enhancing intrinsic healing ability and cd-SF-G for
preventing extrinsic healing to reduce scar and adhesion formations using our new turkey animal model. If successful, we
will have developed and validated the clinically translational interventions to improve functional outcomes following
flexor tendon repair, since both our therapeutics, GMP grade PEP and native SF based material, are one step close to a
clinical trial. Thus, the proposal has a significant impact on both basic science research and clinical translation.

Public health relevance
NARRATIVE Hand tendon injures are very common and need surgical repair, however, the clinical results after repair have not reached patients’ satisfaction because of adhesion and scar formation that glue the injured tendon to the neighboring tissues and harms the hand function. In this study, we will use our newly developed turkey animal model to study tendon healing mechanism and some new treatments using biological agents to improve tendon healing and prevent scar formation.